Promoting Wellness among Native Americans in Urban Areas

Modified Project Summary/Abstract Section
The Montana Consortium for Urban Indian Health, a non-profit dedicated to technical and educational support for the Urban Indian Organizations (UIOs) and their Centers across Montana, will utilize HEAL Initiative OTA-23-007 funding to implement the research and data improvement project “Promoting Wellness among Native Americans in Urban Areas.” The goal of the project is to support research into opioid use and integrated healing approaches in Urban Indian populations and provide insight into the efficacy of evidence-based and culturally integrated programs for opioid and methamphetamine use disorders and chronic pain in this population. Our project has three specific aims:
1. Improve population health surveillance data and clinical data to identify health gaps and disparities among Urban Indian populations in Montana;
2. Adapt evidence-informed interventions to address substance use disorders for Urban Indian populations; and
3. Pilot culturally adapted interventions and assess their efficacy.

During the project, the MCUIH team will use multiple research methods to study patterns and disparities in overdose, prescription management, and chronic pain, and research suitable interventions. MCUIH will work with each UIO in Montana to select potential interventions and adapt them to the needs of each organization’s population and service delivery model. Interventions will be identified and adapted to meet the unique needs of Urban Indian populations, with a focus on culturally relevant and holistic healing methodologies. The project team anticipates that interventions could be Community Health Workers, Recovery Residences, Treatment for Individuals who Use Stimulants (TRUST), and pain-management specific interventions. After program selection, MCUIH will work with UIOs to support initial implementation of the chosen interventions. This deliberate approach ensures that the selected interventions are based upon enhanced use of population- and clinic-level data, align with community needs, and can be implemented effectively with confidence from UIOs and the patient populations of each community.

The work by MCUIH and in collaboration with the UIOs in Montanan will help bridge gaps in care delivery and scientific understanding by improving access to data for examining patterns of overdose, prescription management practices, and chronic pain across UIO communities in Aim 1; adapting evidence-based programs for Montana’s 5 UIOs in Aim 2; and pursuing initial implementation by adapting evidence-informed models in Aim 3; and collaborating with other programs across N CREW. Achieving these aims will positively impact the health and well-being of thousands of Native Americans living in urban centers in Montana and across the country.